BrainGate: Robust Neural Decoding for Veterans with ALS

Intracortical Brain-­Computer Interfaces (iBCIs) aim to restore communication, mobility, and
independence to Veterans and others with paralyzing disorders such as amyotrophic lateral sclerosis
(ALS), stroke, or spinal cord injury. In the late stages of ALS, the progressive loss of mobility is
accompanied by a loss of speech, resulting in tetraplegia and anarthria, or locked-­in syndrome.
Though assistive and augmentative communication (AAC) devices partially address this problem, such
devices become less useful and eventually fail as motor power continues to decline. In contrast, iBCIs
can record the neural activity associated with intended movement directly from cortex. In this renewal
Merit Review application, we propose to expand upon the tremendous progress made in the
development of the investigational BrainGate Neural Interface system toward providing Veterans with
intuitive, always-­available, wireless point-­and-­click control over a computer, tablet, or any other software-­
based communication system.

In the proposed research, we will recruit two Veterans or other people with ALS at the Providence VA
Medical Center to participate in the ongoing BrainGate pilot clinical trial. After placement of two 4x4x1.5
mm, 96-­electrdode Blackrock (Utah) recording arrays in the dominant motor cortex, participants will
engage in two or three recording sessions per week, in their place of residence. The research, which will
also leverage other participants in the multi-­site BrainGate trial, will focus over a year or more with
each participant on the development of improved, robust neural decoders. As a first aim, we will extend
the stability of neural control by developing a new class of relational decoders with improved flexibility,
adaptability, and noise tolerance. This will be facilitated by the use of a discriminative rather than
generative decoding approach that focuses on modeling the probability distribution of the (low-­
dimensional) volitional state outputs based on (high-­dimensional) neural signals. This strategy does not
rely upon an underlying assumption of cosine tuning to endpoint velocity, and allows for flexible, non-­
linear mapping across different intended movements and effectors with increased tolerance to noise. In
the second aim, we will develop new strategies to rapidly calibrate and continuously update neural
decoders. Our new methodology will allow us to transition directly to closed loop control and to calibrate
functional neural decoders within ~1 minute of activating the system. We will also implement new
strategies to maintain continuously both intended direction and click decoding by updating the decoder
after every successful target selection, a useful step toward the design of embedded neuroprosthetic
systems and practical, independent use of an iBCI. In both of these aims, decoders will be compared to
the current state of the art approaches for BCI control. Finally, we will develop a closed loop supervisor
system capable of detecting idle states, automatically switching between desired effectors and triggering
decoder recalibration. These innovations, together with the first use of a high-­bandwidth wireless neural
signal transmitter in human iBCIs, will result in an autonomous, self-­regulating system, helping to restore
independence to users by reducing the reliance on an able-­bodied caregiver. The combination of these
innovations, rigorously tested by a highly experienced and tightly collaborative team of clinicians,
neuroscientists, and engineers, will translate the current iBCI system toward enabling independent,
intuitive, iBCI-­enabled communication by Veterans with ALS.

Public health relevance
Amyotrophic Lateral Sclerosis, also known as ALS or Lou Gehrig’s disease, is a progressive disorder of the nervous system. Veterans have an increased risk of developing ALS, the later stages of which impede the ability to move one’s limbs, to speak, and to breathe without the assistance of a mechanical ventilator. Intracortical Brain- Computer Interfaces (iBCIs) are being developed to allow Veterans and other people with ALS to control external communication devices - such as a computer for email, text messaging, or navigating the web - simply by thinking about the movement of their own hand. A ‘neural decoder’ translates recorded brain activity associated with the intent to move into a command signal for a computer cursor or another assistive device. In this research, we will develop improved, stable neural decoders toward an iBCI that provides Veterans with ALS with intuitive, robust, at- home control of computers and other assistive communication technologies.